Infant Brain Measurement and Super-Resolution Atlas Construction

DESCRIPTION (provided by applicant): The human brain undergoes a dynamic phase of development with rapid structural and functional growth in the first year of life. Insight into thi critical period of development is of paramount importance for understanding the neurodevelopmental origins of psychiatric illness, since brain alterations that are associated with psychosis and other major psychiatric illnesses often occur early during fetal or neonatal life. The recent availability of infant neuroimaging data is making increasingly feasible the precise characterization of development patterns in this period of time. However, computational tools that are dedicated to this purpose are still rare due to the following challenges: (1) Infant scans suffer from significantly lower spatial resolution due to the smaller brain size; (2) Limited by scn time, the achievable signal-to-noise ratio for diffusion-weighted images is typically low; (3) The rapid myelination process results in significant variation of image contrast across different brain regions, which can easily confuse existing computational methods; (4) Techniques developed for adult brain analysis are not directly transferable to infants. This project shoulders the challenging task of overcoming important technological hurdles in creating high- precision computational tools that will automate the quantification of brain development in the first year of life. In Aim 1, we will create a 4D multimodality-guided, level-set-based framework for simultaneous segmentation and registration of serial brain scans acquired from birth to one year of age. This will allow low-contrast images (e.g., the isointense 3- and 6-month scans) to be segmented more effectively by borrowing multimodality information from early time-point (2-week) and/or later time-point (1-year) scans. In Aim 2, we will create a 4D cortical surface reconstruction method for consistent surface reconstruction across different time points. This will help alleviate the imprecision stemming from structural ambiguities in the surface reconstruction process due to low image contrast. In Aim 3, we will create a clustering-based hierarchically organized registration framework that will harness the manifold of anatomical variation of the image population for effective registration of infant brains. This will aid effectve registration of images with large structural differences to a common space for population-based early brain development studies. In Aim 4, we will create super-resolution atlases for infant brains at each time point by using a novel patch-based sparse representation technique. These atlases, when used as templates for brain registration, will lead to significant performance improvement due to their significantly improved structural clarity. All created tools and super-resolution atlases will be integrated into a dedicated infant-brain-analysis software package and made freely available to the research community.

Public health relevance
Public Health Relevance Statement: The computational tools created in this project are directly relevant to public health since they will lead to greater understanding of brain development and to greater capability in identifying neurodevelopmental origins of psychiatric illness. PUBLIC HEALTH RELEVANCE: This project aims at addressing a challenging problem of how to accurately segment serial infant brain images acquired in the first year of life (such as at an approximate interval of 3 months from birth to 1- year-old) and further quantify their longitudinal changes for early brain development study. The successful development of the proposed infant-brain-analysis tools will help understand early brain development and the future studies of neurodevelopmental disorders in the first years of life, and will also help fill up the knowledge gap of early brain development in this period. The final developed infant-brain-analysis algorithms will be made freely available to the research community via NITRC (Neuroimaging Informatics Tools and Resources Clearing house). __SpecificAimsTextDelimiter__ Specific Aims This project shoulders the challenging task of overcoming important technological hurdles in creating high- precision computational tools that will automate the quantification of brain development in the first year of life. The dedicated environment for infant imaging at UNC-Chapel Hill affords us the unique opportunity to accomplish this task. By uniting a dedicated team of image acquisition technologists, medical staffs, and study coordinators, we pioneered applying MRI for longitudinal characterization of cortical/subcortical gray/white matter changes in the first years of life. We have so far acquired more than 650 subjects, who are scanned at a 1-year interval from birth (2 weeks old) to 2 years of age. This dataset has recently been augmented by new data that are scanned from birth to 1 year of age at an approximate interval of 3 months. Our team has recently developed several segmentation methods [2, 3] that are aimed at measuring shapes and sizes of structures in the brains of 2-week-olds (neonates). By borrowing structural information from longitudinal follow-up scans and neonatal atlases, respectively, our methods yield accuracy that is reasonably close to expert-executed segmentation results. However, these methods (1) do not take into consideration the shape information that is critical for improved cortical segmentation; (2) are not tailored for segmenting infant images acquired at subsequent time points; and (3) use only T2- or T1- weighted MR images for segmentation, ignoring useful imaging contrast that can be obtained from other imaging modalities, such as diffusion tensor imaging (DTI). To address these limitations, in Aim 1, we will create a 4D multimodality-guided, level-set- based framework for simultaneous segmentation and registration of serial brain scans acquired from birth to one year of age. This will allow low-contrast images (e.g., the isointense 3- and 6-month scans) to be segmented more effectively by borrowing multimodality information from the 2-week and 1-year scans. In Aim 2, we will further create a 4D cortical surface reconstruction method for consistent surface reconstruction across different time points. This will help alleviate the imprecision stemming from structural ambiguities in the surface reconstruction process due to low image contrast. These methods will allow longitudinal brain changes in the first year of life to be measured automatically and accurately. To characterize early brain development at a population level, we need to spatially map all infant images to a common space. However, the common approach of registering images to a pre-selected template may bias the subsequent data analysis. To solve this issue, we will create in Aim 3 a clustering-based hierarchically organized registration framework that will harness the manifold of anatomical variation of the image population for effective registration of images. This framework will yield higher registration accuracy in a lesser amount of time, by decomposing the large-scale groupwise registration problem into a hierarchical set of smaller and easily solvable registration steps. In Aim 4, we will create super-resolution atlases by a novel patch-based sparse representation technique, for better alignment of infant images during early development study. In summary, the specific aims of this project are: Aim 1 - 4D Segmentation: To develop a 4D multimodality-guided, level-set-based method for simultaneous segmentation and registration of brain images scanned serially from birth to 1 year of age at an approximate interval of 3 months. Our idea is to (1) fuse T1, T2, and DTI images (if available) adaptively according to their changes of tissue contrast over time and (2) use the segmentation results of 2-week and 1-year scans to guide segmentation of 3- and 6-month scans, which have the lowest tissue contrast and always need atlas guidance. This same-subject-image guided segmentation is more accurate and less biased than using population atlas. Aim 2 - 4D Cortical Surface Reconstruction: To develop a 4D cortical surface reconstruction method to simultaneously and consistently reconstruct cortical surfaces across time points for more accurate measurement of longitudinal cortical development in the first year of life. Aim 3 - Organized Registration: To develop a clustering-based hierarchically organized registration framework for more accurate and faster alignment of large datasets (e.g., >650 infant subjects in our current dataset) by decomposing the large-scale registration problem into a hierarchical set of smaller and easily solvable ones. Aim 4 - Super-Resolution Atlases: To build super-resolution atlases for infant brain images via a novel patch-based sparse representation technique. These atlases, when used as templates for brain registration, will lead to significant performance improvement due to the significantly improved structural clarity. All created tools and super-resolution atlases will be finally integrated into a dedicated infant-brain-analysis software package and made freely available to the community via NITRC (http://www.nitrc.org/).